Creation of Dynamic, Non-Stochastic, W Function Informed Methylation Risk Scores (MRS) for Diagnostic/Therapeutic Applications

PROJECT SUMMARY
Current disease diagnostic methods for chronic diseases rely heavily on tools that capture stochastic and causal
biological states, failing to capture the dynamic nature of the diseases. The proposed project aims to develop a
groundbreaking solution by creating a non-stochastic "W Function Epigenomic Roadmap" using systems-based
dynamical modeling to address these limitations. Unlike causal and stochastic measures, this algorithm will
systematically quantify the dynamic interactions of epigenetic markers over time using longitudinal data.
TruDiagnostic is uniquely positioned to lead this effort due to its established expertise in epigenetic testing,
proprietary algorithms, and a robust network of healthcare providers. The project’s high-level aims include (1)
developing a network of epigenetic markers based on the W Function, focusing on shifts in homeostatic set
points over time; (2) validating these findings in two chronic disease models and mortality to understand how
stability in epigenetic networks is altered in disease states; and (3) assess whether our novel algorithms are able
to capture more dynamic changes associated with treatments and interventions compared to traditional DNAm
algorithms. The expected outcome is a transformative diagnostic tool that will allow for personalized, dynamic
health forecasts and identification of critical points for early intervention, offering new pathways for treatment and
improving health outcomes across chronic diseases.

Public health relevance
PROJECT NARRATIVE Chronic disease progression is often influenced by environmental factors as well as aging, and current diagnostic tools rely on stochastic and causal tools which fail to capture its dynamic nature. This project will develop a dynamic, non-stochastic "W Function Epigenomic Roadmap" to quantify the time-dependent interactions of epigenetic markers, enabling more accurate predictions of health trajectories. With TruDiagnostic’s expertise in epigenetic testing and proprietary algorithms, this roadmap will offer personalized health forecasts and identify early intervention points for disease prevention.